NBER Center for Aging and Health Research-Assessing the Impact of the False Claims Act on Healthcare Delivery

OTHER PROJECT INFORMATION – Project Summary/Abstract
Assessing the Impact of the False Claims Act on Healthcare Delivery
This supplement analyzes the effect of the False Claims Act on health care delivery for Medicare beneficiaries
with Alzheimer’s Disease and Related Dementias (ADRD). Patients with ADRD tend to be high users of health
and long-term care services, due to the complexity of their medical needs, the prolonged nature of the disease,
and the ambiguity that surrounds appropriate treatment. As a result, the treatment of ADRD patients may be
particularly prone to fraud and abuse. Indeed, there have been over 150 False Claims Act lawsuits against
hospice providers for admitting ADRD patients whose life expectancy may not have been reasonably evaluated
at less than six months, as required by Medicare policy. An open question is how the False Claims Act may in
turn have impacted the broader treatment and resulting health outcomes of ADRD patients. We propose to study
these impacts. Specifically, to what extent has False Claims Act whistleblowing changed how Medicare
beneficiaries with ADRD are treated, both in the realm of hospice care and more generally? What are the patient
health consequences of these care changes? And which policy tools are effective at eliminating provider waste,
fraud, and abuse without compromising patient care? The parent grant, NBER Center for Aging and Health
Research, supports new research development on important questions relating to health at older ages. While
the parent grant is not focused on Alzheimer's Disease, this supplement would add to a growing collection of
Center-supported research activity on long-term care, particularly among those with cognitive decline.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative This project will provide key insights into health care decision-making for Medicare beneficiaries with ADRD, and how they are affected by the False Claims Act. This is an important population for focused study, because ADRD patients tend to be high users of health and long-term care services due to the complexity of their medical needs, the prolonged nature of the disease, and the ambiguity that surrounds appropriate treatment.